Infant Cognitive Growth Prediction via Centile-based Brain Development and Meta Matching

Abstract
The infant brain undergoes heterogeneous, nonlinear development across multiple phases, with cognitive progression
exhibiting diverse subdomain patterns. Traditional regression and artificial intelligence (AI)-based models linking brain
development to cognitive outcomes often overlook the dynamic nature of brain maturation and cognitive progression. Other
challenges arise from limited sample sizes and unmeasured early lifestyle and environmental exposures. In our prior work,
we developed a computationally efficient, easily interpretable centile-based explainable-AI toolbox, which has been proven
effective in the early diagnosis and prognosis of knee osteoarthritis. In this work, we integrate this centile-based AI with the
recently developed cross-cohort meta-matching techniques to predict infant cognitive growth. We will leverage four infant
brain multimodal magnetic resonance imaging (MRI) databases to derive individual centile score maps from structural and
resting-state functional MRIs, separating influences into anatomical and functional domains. Additionally, we will
incorporate latent neural signatures (LNS) associated with “unseen” non-infant, non-imaging phenotypes—such as
adolescent fluid intelligence, social behavior, or PM2.5 pollution exposure—mapped from two large-scale children and
adolescent datasets. By identifying key biomarkers, we aim not only to elucidate the specific anatomical and functional
brain regions influencing distinct infant cognitive subdomains but also to determine whether LNS metrics mapped from
childhood/adolescence can serve as proxies for underlying cognitive, behavioral, or environmental exposures impacting
infant cognitive development. This meta-matching approach is a novel application with significant potential to uncover
previously hidden implications, linking insights from children and adolescent data to infant brain measures. Two specific
aims guide our project. Aim 1: construct a computationally efficient, easily interpretable centile score-based explainable-
AI toolbox and assess the improvement in infant cognitive prediction with centile score-based imaging biomarkers.
Specifically, we fit developmental trajectories and obtain individual centile score maps for all brain imaging measures,
evaluating them using various machine learning approaches to improve predictions of infant cognitive development. Aim
2: Assess whether integrating unseen non–brain-imaging phenotypes via meta-matching—including adverse childhood
experiences, latent lifestyle and environmental exposures and psychiatric disorders---can further enhance cognitive outcome
predictions. With the transparency of explainable-AI, this project will not only provide a holistic understanding of infant
cognitive development in relation to brain structure and function but also establish a novel framework to link brain regions
activated by childhood and adolescent cognitive, behavioral and environmental factors, as well as psychiatric disorders, to
infant cognitive outcomes. Our expert team, with diverse specializations in neuroimaging, infant brain development,
advanced statistical modeling and machine learning, is committed to sharing findings and methodologies with the broader
scientific community. This dissemination will enhance replicability, foster innovation, and expand the applicability of
insights in early brain and cognitive development. Furthermore, the psychiatric disorders incorporated in meta-matching in
Aim 2 hold clinical significance, potentially aiding in early intervention strategies for neurodevelopmental conditions.

Public health relevance
Project narrative Early infancy is a critical period characterized by rapid brain development and cognitive shifts, with complex, nonlinear, and time-dependent relationships between cognition and brain structure and function. This project employs recently developed centile-based AI and cross-cohort cross-age meta-matching approaches to predict infant cognitive growth by integrating infant brain developmental centile patterns with “unseen” non-infant non-imaging phenotypes mapped from large-scale children/adolescence datasets. By identifying key biomarkers, we are not only to elucidate how specific brain anatomical/functional attributes influence distinct domains of cognitive development, but also to determine whether latent neural signatures—such as those associated with “fluid intelligence”, “social behavior”, “PM2.5”, or “psychiatric disorders” mapped from childhood or adolescence can serve as proxies for underlying cognitive, behavioral or environmental exposures that may impact infant cognitive development.